Coordinating Unit for the Innovative Science Accelerator Program

The goal of the NIDDK Innovative Science Accelerator (ISAC) program is to not only provide funding for highly
innovative hypothesis driven research but to deliver a platform for the KUH research community to collaborate,
exchange ideas and find resources that will accelerate innovation in areas of interest to that community. Our
laboratory has extensive experience in developing these types of resources and managing the activities of
national consortia. We are currently the Coordinating Units (CU) for two NIDDK consortia, the Mouse
Metabolic Phenotyping Centers (MMPC) and the Diabetic Complications Consortium (DiaComp). Both
consortia are NIDDK funded initiatives that provide an environment to foster communication and collaboration
between investigator communities involved in metabolic and diabetic complications research. Each sponsors
annual meetings in relevant scientific areas, solicits and funds pilot projects in high impact areas of NIDDK
research, and supports websites to serve their respective scientific communities. Over the last 14 years, our
group has developed an extensive infrastructure to successfully managed the coordinating units (CU) for these
NIDDK funded consortia (MMPC, 2006-present, DiaComp, 2011-present). The ISAC-CU will be responsible for
supporting ISAC investigators through the use of opportunity pools (funding programs), manage/maintain the
website/resources and administratively organize the meetings and workshops sponsored by ISAC to engage
the greater KUH scientific community. The ISAC-CU is responsible for creating and maintaining the
administrative, scientific and informatics infrastructure necessary to organize and facilitate ISAC’s operations.
The goal of this proposal is to provide that infrastructure. We will build upon the success of the current CU
infrastructure to provide ISAC with a robust and comprehensive service oriented solution that supports the
unique aspects of this consortium.

Public health relevance
The National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) is providing funds to establish the coordinating unit (CU) for the Innovative Science Accelerator (ISAC) Program. The CU will coordinate the interactions of the ISAC awardees, provide financial management for opportunity pool programs, interact with the NIDDK Program Officers and External Expert Panel, support the annual ISAC scientific meetings as well as provide a national web portal for ISAC in order to disseminate information and provide an organizational infrastructure for the program. This application will provide the infrastructure for the CU for ISAC.